Brain ACE2 in Alzheimer's disease in relation to COVID-19

Summary/Abstract
Currently the world is suffering from the pandemics of coronavirus disease 2019 (COVID-19), caused
by severe acute respiratory syndrome coronavirus 2 (SARS-CoV-2) that uses angiotensin-converting
enzyme 2 (ACE2) as a receptor to enter host cells. Millions of people have been infected with SARS-CoV-
2 and over 1 million people have died of COVID-19 worldwide, causing serious health, economical, and
sociological problems. In Ukraine, a low- and middle-income country (LMICs) with a population of 42
million, 400,000 cases have been confirmed with 7,000 deaths. The aging population is highly susceptible
to be severely affected by and die of COVID-19. Neurological manifestations have been reported to occur
in a large number of COVID-19 patients, suggesting that this disease may also exert the long-term
adverse neurological consequences. However, the effects of SARS-CoV-2 on human host cells,
particularly those in the brain, have not been defined. Lack of such knowledge interferes with the
development of therapeutic strategies to combat COVID-19. The long-term objective of our research is to
define the relationships between neurological disorders and COVID-19. We recently found that
Alzheimer's disease patients have the upregulated hippocampal ACE2 expression. In this international
collaborative exploratory/pilot Fogarty project, we will test the central hypothesis that the oxidative stress
in Alzheimer's disease promotes cell signaling and gene expression mechanisms to upregulate ACE2 that
in turn increases the infection by SARS-CoV-2 in the brains of these patients. This project will also engage
in research capacity building for Ukraine. We plan to accomplish the objective by addressing the following
specific aims: (1) Engage in research capacity building for Ukraine, one of low- and middle-income
countries; (2) Define the mechanism of ACE2 gene expression in Alzheimer's brain; and (3) Identify the
role of brain ACE2 in Alzheimer's disease in relation to COVID-19. This project is innovative because it will
address a novel pathology of COVID-19. Results of this project are significant because they are expected
to contribute to the development of new therapeutic agents to reduce the mortality and morbidity caused
by COVID-19 that occurs largely in the aging population while building the research capacity in Ukraine.
.

Public health relevance
Project Narrative Currently, the world is suffering from the pandemic of coronavirus disease 2019 (COVID-19) that is caused by a virus called severe acute respiratory syndrome coronavirus 2 (SARS-CoV-2), affecting many people, especially elderlies. Because our initial observations noted that the brains of Alzheimer's patients have more receptors for SARS-CoV-2, this project will examine how SARS-CoV-2 receptor is increased in Alzheimer's patient brains and whether the brains of these patients are affected by COVID-19 for the purpose of providing information that leads to the development of therapeutic strategies to combat this pandemic and help many people, especially the elderly. In addition, this project is designed to help enhance the research capacity in Ukraine, a low- and middle-income country.